Fluorescent Probes that Span the Spectrum for Multi-Color Imaging of Peroxynitrite in Living Cells

Project Summary/Abstract
Reactive oxygen species and reactive nitrogen species are oxidative metabolites that play important roles in
human health and disease. While these oxidative metabolites are required for a diverse array of cellular
processes, including cell death, differentiation, and signaling, uncontrolled production of reactive oxygen and
nitrogen species can contribute to the underlying inflammation of cancer, heart disease, respiratory diseases,
autoimmune diseases, and stroke. We are developing new imaging probes that span the visible spectrum to
map reactive oxygen and nitrogen species with improved specificity and versatility to help understand the roles
these oxidative metabolites play in inflammation. The scientific premise is that building an imaging toolkit for
oxidative metabolites will provide new tools to further our understanding of the dynamics of reactive oxygen and
nitrogen species in redox biology. This R15 application uses principles from physical organic chemistry, synthetic
chemistry, and molecular probe design to develop new peroxynitrite-specific imaging probes with optical
characteristics enable multi-analyte imaging. These tools will be applied in cell culture models of macrophages.
Specifically, we will understand the structure-function relationship of diazaborines, a new motif for selective
metabolite detection, and pursue diazaborine-based probes with excitation/emission profiles spanning from blue
to green to red. Embedded in this work is a research-centric pedagogy to train undergraduates at the Colorado
School of Mines to join an increasingly collaborative and diverse biomedical workforce.

Public health relevance
Project Narrative (Public Health Relevance Statement) Reactive oxygen species and reactive nitrogen species are required for a range of cellular functions, including cell differentiation and cell death. Dysfunctional reactive oxygen and nitrogen species production is connected to chronic inflammation, which underlies many diseases including cancer, heart disease, and respiratory diseases. We are developing new chemical probes and imaging platforms for imaging these oxidative metabolites to help decipher how they contribute to healthy and disease states.